Core I: International

Core I: International (Intl) Project Summary/Abstract
The overall objective of the International (Intl) Core is to expand HIV research opportunities in low- and middle-
income countries (LMIC). We achieve this objective by 1) Mentoring for Momentum (M4M), addressing long-
term career development needs of emerging investigators pursuing international HIV research; 2) Advancing
Decolonization (AD), implementing policies to counteract inequities that impede LMIC researchers’ ability to
conduct HIV research; and 3) moving from Local to Global (L2G), boosting international HIV research across the
SD CFAR through advising local investigators who are planning or already conducting projects in other countries.
The Intl Core supports the SD CFAR’s mission, major goals, and initiatives through the following specific aims:
1. Training and Quality Assurance Unit: To foster international HIV investigators and SD CFAR members by
evaluating Intl Pilot and other research proposals; provide written, live/virtual, or recorded trainings on study
management, publications, and grant writing; and offer customized assistance to San Diego-area
investigators leading or planning international HIV studies.
2. Regulatory Unit: To assist international HIV researchers and SD CFAR members in fulfilling regulatory and
financial requirements for their studies through collaboration/consultation with other SD CFAR cores and
appropriate NIH contacts, e.g., the Office of Human Research Protections.
3. Communications Unit: To promote international HIV research; ensure research interests and needs of
emerging international HIV investigators are addressed to the extent possible; produce training materials
under the direction of the Training/Quality Assurance Unit; maintain contact between Intl Pilot grant
applicants and recipients, SD CFAR cores, and local/international community advisory boards.
4. Innovation Unit: To identify new international HIV research opportunities in recognized NIH HIV/AIDS
research priorities, including implementation science, training, infrastructure, and capacity building; promote
global health equity throughout all SD CFAR-funded studies; and share promising opportunities with SD
CFAR researchers to support our Center’s mission “to improve the lives of people with HIV and to stop new
infections, both locally and globally.”
Progress: These aims are designed to assist emerging investigators and those new to international HIV research.
SD CFAR grant funding in LMIC also provides much-needed equipment and infrastructure. The Intl Core offers
training and mentorship to guide investigators to successful, independent careers. From 2006 to 2022, we have
supported a total of 83 international studies funded by the SD CFAR Developmental Core. These studies have
resulted in 259 peer-reviewed papers and $63.2 million in subsequent funding (ROI $14.65).